AVON--NORMAL HUMAN MELANOCYTE CULTURE

This grant is used to develop better culture conditions for normal human melanocytes. We are studying the expression of mRNA for proopiomelanocortin and translational products for alpha-MSH and other POMC derived peptides. In addition, we are studying the immune system of the depigmenting mouse which cannot be contact sensitized.